End-of-life treatment preferences of Latino Medicare beneficiaries with cancer

DESCRIPTION (provided by applicant): End of Life Treatment Preferences of Latino Medicare Beneficiaries with Cancer Principal Investigator: Isabel Torres, Dr.P.H. The overall goal of the NCI K01 career development plan is to provide the candidate with a program of mentored research activity and study in the areas of palliative cancer care, health disparities and outcomes research to launch an independent research career with specialization in the integration of these research areas. The five-year plan is carefully designed to 1) obtain further research experience in the areas of palliative cancer care, health disparities and health services research; 2) advance skills related to the design and analyses of prospective palliative care studies through training in advanced statistical methods; 3) improve skills needed to develop and test new instruments and performance measures to improve the accuracy of assessing quality outcomes for both English and Spanish speaking Latinos with cancer; 4) acquire further grant writing skills and experiences, resulting in the submission of an R01 grant before the end of the support period. Properly identifying the end-of-life preferences of cancer patients is a national healthcare priority and understanding the clinical, cultural, psychosocial and system-level factors that influence these decisions is paramount for clinicians and policymakers trying to respect patient preferences and improve their quality of care. The aim of the study is to determine if declining health status influences the end-of-life treatment preferences in Latino Medicare beneficiaries with cancer and how these preferences are modified by factors such as acculturation, health literacy, medical mistrust, provider ethnicity or the use of interpreters, or patient navigators. Participants will be 100 older Latino Medicare beneficiaries with breast, colorectal or prostate cancer, stage III or greater, and 100 contemporaries without cancer. Persons without cancer will be surveyed only once cross-sectionally and those with cancer will be interviewed at baseline and then monthly until twelve months or death to capture the preferences of both those who are undergoing rapid decline and those who are stable. Understanding the relationship between declining functional status and the treatment preferences of older Latinos with cancer has important clinical and policy implications, as findings could influence the use of written documents for advance care planning and inform the content and frequency of discussions that may be needed to capture changes in preferences triggered by changes in health status. We expect the proposed area of study and research that integrates palliative cancer care and health disparities research and applies prospective analytic methods to investigate a critical and understudied area to make a significant contribution to cancer care research.

Public health relevance
PUBLIC HEALTH RELEVANCE: End-of-Life Treatment Preferences of Latino Medicare Beneficiaries with Cancer Latinos are the fastest growing segment of the older population and new Latino cancer cases are predicted to double within the next twenty years. A person with cancer's choices to forgo life-extending treatment may change over time and as their health declines, yet identifying their choices related to one of life's most difficult periods is not always easy. This study will determine if the combination of declining health, cultural factors and meeting the cultural and language needs of Latino cancer patients, influence their end-of-life treatment choices. End-of-Life Treatment Preferences of Latino Medicare Beneficiaries with Cancer Latinos are the fastest growing segment of the older population and new Latino cancer cases are predicted to double within the next twenty years. A person with cancer's choices to forgo life-extending treatment may change over time and as their health declines, yet identifying their choices related to one of life's most difficult periods is not always easy. This study will determine if the combination of declining health, cultural factors and meeting the cultural and language needs of Latino cancer patients, influence their end-of-life treatment choices. __SpecificAimsTextDelimiter__ 4. RESEARCH PLAN 4a. STATEMENT OF HYPOTHESES AND SPECIFIC AIMS Accurately assessing and respecting the end-of-life (EOL) treatment preferences of cancer patients facing life threatening illness is increasingly being recognized as a national healthcare priority53 and speaks directly to the mission of the National Cancer Institute. However, identifying treatment preferences related to one of life's most difficult periods is not always easy. There is a body of evidence from distinct studies that clinical patient characteristics, ethnicity, educational level, psychosocial factors, and health services-related factors may influence the EOL preferences of patients. An important line of inquiry also suggests that EOL preferences, particularly choices related to forgoing life extending treatment for instance, may change over time, and are context specific.61,62 However, findings in this area are not unequivocal and an added complexity is that findings related to the direction of the association between declining health status and EOL preferences have been inconsistent. 63-69 Few studies have prospectively investigated the combination of clinical, demographic, psychosocial and health service indicators that may influence the end of life treatment preferences of persons with cancer - particularly in older Latinos both with and without cancer. There is limited research on older Latinos, one of the fastest growing segments of the older population and among the least likely to receive quality care.70,71 The lack of knowledge in this area presents a series of challenges for clinicians and caregivers attempting to make critical decisions that accurately reflect the wishes of their patients and loved ones. Understanding the relationship between declining functional status and the treatment preferences of older Latinos with cancer has important clinical and policy implications, as findings could influence the use of written documents for advance care planning and inform the frequency of discussions that may be needed to capture changes in preferences triggered by changes in health status. The overall goal of the proposed career development and research plan is to provide me with a program of mentored research activity and study in the areas of palliative cancer care disparities research and outcomes research in support of my efforts to establish myself as independent researcher specializing in the integration of these areas. The primary objective of the research project, which is a critical step in pursuit of that goal, is to investigate how declining health status influences the EOL treatment preferences in Latino Medicare beneficiaries with cancer and to examine if and how these preferences are modified by predisposing characteristics (i.e., acculturation, health literacy, medical mistrust) and/or provider-related characteristics (i.e., ethnicity, language used, provision of interpreters, or patient navigators). The central hypothesis of the application is that there is a direct association between declining functional status and EOL treatment preferences in older Latinos with cancer and that this association will be modified by acculturation, health literacy, medical mistrust and provider-related characteristics such as provider ethnicity and meeting the patient's language needs. This hypothesis has been formulated on strong evidence that changes in health status may influence decisions to forgo life sustaining treatment and on findings from other studies that suggest that factors specific to many Latinos such as acculturation, health literacy, medical mistrust and the provision of services such as interpreters, may influence their interactions with the healthcare system and ultimately the quality of care they receive. The rationale for this project is that its successful completion is expected to provide new evidence that elucidates the dynamic relationship between EOL treatment preferences and functional status, and the potentially modifying effects of mutable factors such as health literacy or the use of interpreters in the clinical setting while, and at the same time, it provides the means of establishing the PI's independence as a researcher. We are particularly well prepared to undertake the proposed research because the multidisciplinary team that has been assembled has the scope and breadth of experience and expertise (palliative care, health services, health disparities research and biostatistics) to obtain definitive outcomes (see Preliminary Studies and Biographical sketches). Such findings are expected to inform the development of larger studies and may provide critical guidance to the development of culturally appropriate care for older Latinos with cancer. We plan to test our central and specific hypotheses and accomplish the objectives of this application by pursuing the following three specific aims: 1. To determine if declining functional status influences the end-of-life treatment preferences of older Latino Medicare beneficiaries with cancer. Hypothesis 1: Cancer patients with low functional status will report a greater preference for palliative and comfort care measures compared to cancer patients with high functional status. Hypothesis 2: Cancer patients will shift their preferences from life sustaining treatment preferences to palliative/comfort treatment preferences as their disease progresses as assessed by repeated measures of "functional status". 2. To determine if predisposing characteristics (i.e., acculturation, health literacy, medical mistrust) and/or provider-related characteristics (i.e., ethnicity, language used, provision of interpreters, or patient navigators) modify the association between end-of-life treatment preferences and declining health status in older Latinos Medicare beneficiaries with cancer. Hypothesis 3: Latino cancer patients with low levels of acculturation, health literacy and high levels of medical mistrust will be more likely to prefer life-sustaining treatment than Latino Medicare beneficiaries with high levels of acculturation, health literacy and low levels of medical mistrust. Hypothesis 4: Latino cancer patients whose providers are Latino, or receive care in their preferred language will be more likely to prefer an EOL treatment approach that focuses on patient comfort over life sustaining treatment than cancer patients whose providers are not Latinos, or who do not receive care in their preferred language. Hypothesis 5: The association between EOL treatment preferences and functional status among older Latino Medicare beneficiaries will be modified by acculturation, health literacy, medical mistrust and provider-related characteristics (i.e., ethnicity, language used, provision of interpreters, patient navigators). 3. To identify if the end-of-life treatment preferences of Latino Medicare beneficiaries with cancer differ from those of older Medicare beneficiaries without cancer. Hypothesis 6: Latino Medicare beneficiaries without cancer will be more likely to prefer a life sustaining treatment plan than Latino Medicare beneficiaries with cancer. Secondary Informed Decision Making (IDM) Research Questions: 1) What are the roles of the patient, the family, and physicians in EOL decision-making and do these roles differ by levels of acculturation, health literacy, education and medical mistrust? 2) Are differences in the EOL decision-making process associated with EOL treatment preferences (e.g., comfort vs. aggressive care)? The proposed research is innovative because this will be first prospective study to determine if there is an association between EOL treatment preferences and a series of clinical (functional status), demographic and psychosocial (ethnicity, acculturation, health literacy, medical mistrust) and provider-related (ethnicity, language used, provision of interpreters, or patient navigators) factors in older Latino Medicare beneficiaries with cancer. As a tertiary aim, the study also allows for the comparison of the EOL treatment preferences of persons with cancer to those of persons without cancer by incorporating a comparison group of contemporaries without cancer. It is anticipated that this innovative approach will yield the following expected outcomes: First we will have identified if and to what degree declining functional status changes the EOL treatment preferences in a particularly vulnerable population, older Latinos with cancer. Second, we will produce findings that will yield important insights into how the combination of clinical, cultural, psychosocial and provider-related factors influence their treatment choices and how these factors modify the relationship between declining functional status and preferences. Third, we will generate important comparisons between the EOL treatment preferences of Latino Medicare beneficiaries with cancer and their contemporaries without cancer that will underscore the impact that a diagnosis of cancer may have in this population of older Americans. These expected outcomes are expected to position the candidate to submit a competitive R01 award during the fifth year of funding. Thus, in addition to contributing vertically to the fields of palliative care, health disparities and outcomes research, the results are expected to have an important positive impact on the planning and provision of care of older persons with cancer and the candidate's career development.